Structural characterization of native HBV capsids and virions from human cells

PROJECT SUMMARY
Hepatitis B virus (HBV) infection is a global public health concern. Despite effective vaccines to prevent this
disease, current approved treatment rarely leads to a complete cure. There is an unmet medical need for
developing new therapeutics for HBV infection that can lead to a sustained response. Targeting HBV capsid
assembly process has become an emerging strategy for developing new antiviral treatment for HBV. However,
many efforts have been made by using different capsid protein (Cp) constructs expressed in Escherichia coli to
mimic or reconstitute native-like viral particles. Yet, these structures cannot correctly represent the native HBV
conformations due to the lacks of nucleic acid binding domain of the Cp, viral genome, and viral enzymes, all of
which are required for viral replication. Furthermore, the lack of post translational modifications of the Cp also
hampers the interpretation between observed Cp structures to the biomedical data obtained from the mammalian
cell culture system or experimental animals. To date there is no available high-resolution native HBV structures,
which is a major gap in knowledge of the HBV field.
In this proposal, we aim to use cryo-electron microscope (cryo-EM) to directly characterize the structures of
native HBV capsids and virions from human cells. In Aim 1, we will determine the high-resolution structures of
purified intracellular HBV capsids with different types of viral genome. We will address the key questions
concerning the structural dynamics of HBV capsids during genome maturation. We will also determine the
structure of the HBV reverse transcriptase (RT) and its location during reverse transcription to help understand
its mode of action (whether the RT is static or moves). In Aim 2, we will investigate the high-resolution structures
of secreted HBV virions. This aim will address the questions concerning how HBV capsids interact with the viral
envelop proteins. Finally, experimental findings from these two Aims will be integrated to elucidate capsid
dynamics during HBV replication and illuminate the molecular determinant(s) of HBV envelopment.
This proposal is expected to solve 4 types of intracellular HBV capsid structures (empty, RNA-filled, single-
stranded DNA-filled, and mature partially double-stranded DNA-filled capsids) and 3 secreted enveloped HBV
virion structures (empty, mature, and prematurely secreted virions) using cryo-EM to define the conformational
changes of the capsid during viral replication, particularly in the context of different viral genome forms and
interactions between the capsid and surface proteins. The methodology exploits appropriate mutations of Cp
and RT to ensure obtaining homogenous particles of the various types as described above, which can be further
computationally classified to minimize cross-contamination.
Understanding the native HBV structures will provide valuable new information for HBV biology and guide the
design of novel antiviral drugs in the future. The project is anticipated to impact fields ranging from HBV,
molecular virology, antiviral drug development, and macromolecular structure and function.

Public health relevance
PROJECT NARRATIVE Hepatitis B virus (HBV) is responsible for 257 million infection worldwide and currently there is no effective treatment to cure the disease. Nearly all high-resolution HBV structures published to date utilized E Coli expression system that either 1) lacks the nucleic acid binding domain, or 2) lacks post-translational modification, or 3) encapsidates non-viral nucleic acids; thus, making it difficult to correlate the observed structures with biomedical data. This proposal aims to dissect native high-resolution HBV structures from human hepatoma cells and will provide new structural insights that contribute to our understanding of disease pathogenesis.